Structure and Dynamics of Telomeres and Telomerase

Project Summary
Telomeres are essential structures located at the ends of linear chromosomes that protect genomic integrity
by preventing chromosomal fusion, degradation, and activation of DNA damage response pathways. The
telomerase reverse transcriptase maintains telomere length to compensate for telomere erosion by adding
short DNA repeat sequences to chromosome ends. In the absence of telomerase, telomeres progressively
shorten with each cell division due to the end-replication problem and nucleolytic processing. Critically short
telomeres ultimately induce cellular senescence or apoptosis. Dysregulation of telomere homeostasis has
been implicated in many human diseases, including cancer and rare genetic syndromes. Yet, the molecular
mechanisms underlying telomere/telomerase biology and the interplay between telomere dysfunction and
disease pathology are still not fully understood. With our previous NIGMS funding, we investigated
telomeres/telomerase from ciliates, yeasts, and vertebrates to uncover conserved structural features of
telomerase RNA, protein subunits, and telomere DNA. We used a combination of biochemical, structural,
computational, and novel single-molecule biophysical methods to study the function and dynamics of
telomerase and telomere DNA. Our results, together with the progress made in other laboratories, advanced
detailed mechanistic models for telomerase enzyme assembly, spatiotemporal regulation of telomerase
recruitment to telomeres, telomere chromatin remodeling by shelterin proteins, and coordinated
conformational changes within telomerase during its complex catalytic cycle. We are now uniquely positioned
to critically evaluate these models with our established state-of-the-art methodologies. The insights gained
from this research will provide a framework for the development of new therapeutic strategies and preventive
measures for telomere-related disorders. Funding from the MIRA will provide the necessary resources and
ﬂexibility to pursue new avenues of mechanistic research within the rapidly developing ﬁeld of telomere and
telomerase biology.

Public health relevance
Project Narrative The maintenance of telomeres by telomerase is necessary to support continued cell growth. Telomere and telomerase dysfunction arise in the large majority of human cancers and certain rare genetic syndromes. This work will signiﬁcantly advance our understanding of the molecular mechanisms governing telomere length control and pave the way for the development of novel therapeutic interventions for human disease.